MOLECULAR BIOLOGY AND PATHOLOGY OF NEOPLASIA WORKSHOP

Support is requested for continuation of a intensive one-week Summer Workshop in Keystone, Colorado, on the molecular biology and pathology of neoplasia for graduate students, postdoctoral trainees, and senior scientists engaged in basic cancer research. Many investigators in the cancer field, particularly those working in the area of molecular biology, have had little exposure to the biology and pathology of human cancer. The purpose of this Workshop is to provide a unique training experience in cancer biology, pathology, and related disciplines for students that will enable them to pursue avenues of investigations that will contribute to our understanding of the etiology, treatment, diagnosis, and prevention of cancer. The AACR considers this Workshop to be an essential training opportunity for young basic researchers because it provides the broad overview of the problem of human cancer that they need to bring their specialized investigations to fruition. The workshop program is developed by its faculty, a group of cancer researchers working in tumor biology, pathology, and other appropriate scientific disciplines at a variety of institutions in the United States. The Workshop program is also regularly reviewed by the distinguished scientists who serve on the Board of Directors and the Special Conferences Committee of the American Association for Cancer Research (AACR), a scientific society of 14,000 members worldwide working in all aspects of basic, clinical, and translational cancer research. The AACR's experienced staff administers the Workshop; it is able to bring to this program not only its six years of experience with the current project, but also an excellent track record in the operation of two similar programs (also funded by the NCI) which takes place every Summer.